Acquisition of a Supercritical Fluid Chromatography Mass Spectrometer System

Project Summary
This proposal requests funding to purchase a Waters Acquity UltraPerformance Convergence
Chromatography (UPC2) system equipped with photodiode array and single-quadruple mass spectrometer
detectors. The instrument will be used to characterize the numerous novel molecules synthesized at the
University of Wisconsin-Madison, and will be located in the Department of Chemistry Synthesis and Catalysis
Center. Projects that will be supported by this instrument are addressing fundamental biological questions and
challenges in drug synthesis. The Yoon group is developing new general strategies for the controlled
photochemical synthesis of complex organic molecules and small-molecule therapeutics. The Stahl group
develops new oxidation and oxidative coupling reactions that form carbon-carbon and carbon-heteroatom bonds
with broad impact in medicinal chemistry and drug discovery. Research in the Wickens group combines electro-
and photochemical methods to selectively transform simple and inexpensive molecules into compounds of
medicinal importance, facilitating the development and large-scale preparation of new pharmaceuticals while
simultaneously reducing the cost of life-changing medicines. The Schomaker group uses mechanistic insight to
tune the reactivities of unusual intermediates to achieve mild, versatile syntheses of stereochemically rich,
densely functionalized N-hetero- and carbocycles, including those in bioactive molecules that bind to specific
ribosomal subunits. The synthesis of macrocyclic compounds displaying stable axial chirality that play important
roles in biology and medicine is the focus of research in the Gellman lab, where new bifunctional foldamer
catalysts are being developed to exploit non-traditional peptide scaffolds that orient reactive groups to achieve
high stereoinduction during macrocyclization. The Martell group's growing research program is developing hybrid
biological-synthetic catalysts consisting of three-dimensional, self-assembled DNA and protein scaffolds as
catalysts for stereo- and regio-selective transformations, coupling reactions, and the tagging of endogenous
proteins to locate the specific subcellular regions where they reside. And, the Blackwell group is addressing the
urgent global need for new antimicrobial therapies with an integrated research program at the interface of
chemistry and biology focused on chemical signaling pathways that allow bacteria to act as a group at high cell
densities and activate behaviors that significantly impact human health, including the initiation of deadly
infections. The ultimate goal of all these projects is to find ways to improve human health by discovering new
therapies and drugs.

Public health relevance
Project Narrative Acquisition and installation of a Waters UPC2-MS instrument will enable scientists to characterize diverse new molecules derived from innovative synthetic methodology efforts at UW-Madison. The research targets medicinally relevant building blocks and complex molecules with increased structural diversity and stereochemical density. The requested instrument has state-of-the art resolving powers for chiral and achiral molecules, coupled to robust optical and mass detectors to support rapid assays needed to support high- throughput synthesis and screening. The research supported by this instrument will elucidate new ways to probe bacterial cell-cell signaling, discover novel disease therapies, and develop new catalytic methods for pharmaceutical synthesis.